Project 2

PROJECT SUMMARY
Acute myeloid leukemia (AML) is the most common acute leukemia in adults and is a growing public health
burden as the population ages. Dose-intensive induction and consolidation chemotherapy dramatically reduces
tumor burden and induces clinical complete remission in the majority of individuals. However, AML patients
typically relapse with chemoresistant disease and patients over 60-years-old, constituting most AML cases,
exhibit dramatically worse outcomes. Thus, improved therapeutic approaches are imperative. The major
overarching hypothesis of this Program Project is that increasing endogenous pro-death ceramide (Cer), while
diminishing pro-survival Cer metabolites, will yield efficacious treatments for AML. Furthermore, we propose that
AML patients can be risk stratified based on their sphingolipid (SL) states, which can contribute to more
efficacious treatment choices. We have validated acid ceramidase (AC) as a driver of Cer detoxification to pro-
survival sphingosine-1-phosphate (S1P) and established the promising, but incomplete, single-agent efficacy of
AC inhibitors in AML. Our innovation & significance lie in our recent discovery that AML cell lines and patient
samples stratify into distinct SL subtypes (SMhigh/low) that (a) show clear evidence of activated ceramide
detoxification routes in AML and (b) establish a gene expression signature that is predictive of clinical outcome
in AML. We have also identified detoxification pathways that subvert therapeutic efficacy of SL-targeting
therapeutics via Cer de-acylation, phosphorylation, glycosylation, or conversion to sphingomyelin (SM). These
observations form the central premise that profiling Cer detoxification pathways will inform rationally targeted
blockades to drive accumulation of multiple, distinct Cer “pools.” Three specific aims will be pursued to explore
the hypothesis that identification and targeting of Cer clearance routes will predict and improve outcomes in
AML. Aim 1 will determine efficacy and mechanisms of AC inhibition in combination with clinically relevant AML
therapeutics (venetoclax and 5'-azacytidine). These agents are known to impact SL metabolism and create
vulnerabilities to combinatorial regimens that block Cer clearance. We will rationally apply Cer generators (with
Project 1) and define their potency to collapse AML-specific mitochondrial rewiring (with Project 3). Aim 2 will
develop strategies to optimize AC targeting and translational impact by characterizing in vivo efficacy of new AC
inhibitor nanoformulations and define genes that modulate sensitivity to AC inhibition. We will also utilize gene
expression profiles from SMhigh/low AML samples to predict therapeutic vulnerabilities across SL subtypes. Aim 3
will advance SL subtypes (SMhigh/low) as predictive biomarkers of clinical outcomes in AML. We will utilize clinical
trial samples from patients over 60 (aged AML) to refine the predictive classifier to a reduced feature set feasible
for clinical application. We will also validate the gene set predictor vs. SL levels and test the refined parameters
in an independent aged AML cohort. This work will optimize AC-targeting and Cer-driven therapeutics for clinical
translation and create a path to apply our SMhigh/low risk classifier for clinical management in AML.

Public health relevance
PROJECT NARRATIVE This study focuses on new approaches to exploit the dysregulated sphingolipid metabolism landscape in acute myeloid leukemia (AML). Primary goals are to define the influence of ceramide clearance and flux pathways on response to AML therapeutics and to establish the predictive value of sphingolipid profiles in AML patients over the age of 60. Knowledge gained from this work will be utilized to optimize ceramide-targeting therapeutics, enhance existing AML therapeutics, and identify high risk patient groups based on sphingolipid metabolism for improved treatment selections and clinical outcomes in AML.